COG NCTN Network Group Operations Center - Year 11 STAR Act MCI and PEC Supplement

PROJECT SUMMARY
Since the introduction of chemotherapy for the treatment of childhood leukemia more than 60 years ago, the
prognosis of childhood cancer has improved dramatically. The overall 5-year survival rate for childhood cancers,
many of which were uniformly fatal in the pre-chemotherapy era, is now 86%. Progress for a number of childhood
cancers, however, has been limited, with approximately 50% of children with acute myelogenous leukemia, 50%
of children with high-risk neuroblastoma, and more than 90% of children with brainstem glioma, still succumbing
to their disease. In the US, cancer remains the leading cause of death from disease in children greater than one
year of age. Moreover, the late effects of cancer treatment, including permanent organ and tissue damage,
hormonal and reproductive dysfunction and second cancers, are of special concern, with more than 40% of the
500,000 survivors of childhood cancer (estimated as of 2020) experiencing a significant health related quality of
life complication from childhood cancer and its treatment. Thus, despite our advances, development of new
therapeutic approaches must be a priority for childhood cancer basic, translational, and clinical researchers.
The Children’s Oncology Group (COG), the world’s largest organization devoted exclusively to childhood and
adolescent cancer research, was founded 24 years ago. The COG’s multidisciplinary research team, comprised
of more than 9,000 members, conducts research at more than 220 leading children’s hospitals, universities, and
cancer centers. This proposal is for COG, as part of the National Cancer Institute’s (NCI) National Clinical Trials
Network (NCTN), to continue its collaborative research work that supports the mission of improving the outcome
for all children with cancer. The COG will design and conduct clinical-translational studies for children with cancer
that build on an increasing understanding of the molecular basis for pediatric malignancies and which have the
highest potential to improve outcomes. Using innovative clinical trial designs suitable for the study of rare
diseases, we will study novel therapeutic approaches including but not limited to targeted small molecule
drugs, immunotherapies, and cellular therapies. The COG research portfolio importantly also includes clinical
trials focused on improving the quality of life for children with cancer and childhood cancer survivors. As more
than 80% of children diagnosed with cancer in the US are treated at COG member institutions, COG has the
ability to offer a diverse population of children with cancer and their families the opportunity to participate in
innovative research. This research effort includes collecting and annotating biospecimens from all children with
cancer, providing the foundation for discovery and accelerating the most promising research efforts conducted
in laboratories around the world. The proposal is for support of the COG Network Operations Center, clinician-
scientists who develop and conduct research, and for member sites to participate through enrollment of eligible
subjects.

Public health relevance
PROJECT NARRATIVE The Children’s Oncology Group (COG) is the world’s largest organization devoted exclusively to childhood and adolescent cancer research. Over 220 leading children’s hospitals, universities, and cancer centers across US, Canada and other countries participate in COG research, which is focused on developing better treatments that can improve the cure rate and outcomes for all children with cancer.